6th International Single Nucleotide Polymorphism (SNP)

DESCRIPTION: (provided by applicant) The proposal seeks NIH funding to speakers invited to present at the 6th International Single Nucleotide Polymorphism (SNP) meeting to be held in Hilton Wilmington Christiana Conference Center, Christiana, Delaware, November 19 to 23, 2003. The objective of the meeting is to present a three day program, which will include presentations by internationally known experts in genomics, population genetics, molecular evolution, statistical genetics, and molecular epidemiology. Sessions will be devoted to diversity and evolution, genome structure, population genetics, haplotype structure, tools and strategies, haplotype analysis, phenotype and disease, ethical, legal and social issues in human genomics. The field of SNP analysis is quickly expanding, based on the exponential increases in the public databases for SNPs and advances in technical and analytical approaches. Because the field is advancing rapidly, an annual meeting is essential to provide the forum for presentation and analysis of current trends in related fields. Past meetings have been reported in Science and Nature Genetics. Moreover, many new collaborations and ideas have been generated at this meeting. This is the sixth consecutive year for this academic meeting, which has alternated between venues in Europe and the United States.